Opioid Prescribing and Health outcomes among Cancer Survivors

PROJECT SUMMARY
The population of Americans who are free of cancer 5-years post-cancer diagnosis, long-term survivors, is
growing. Many are expected to develop and suffer from chronic pain, of which, many will be prescribed opioids
for chronic pain management, contrary to prescribing guidelines. Previous literature has demonstrated that
cancer survivors may experience prolonged opioid use or higher rate of opioid prescribing or are more likely to
receive a high dose of prescription opioid than individuals who have not been diagnosed with cancer. However,
these previous studies are from outside the United States or are regional (e.g. Texas), have a different
definition of cancer survivor (e.g. beginning from date of diagnosis, 5 years post-cancer diagnosis), have not
examined the roles that providers and hospitals may have on patient high-risk opioid use, and have not
assessed the risk of an opioid related adverse outcomes. Furthermore, no studies have examined if federal
rescheduling of hydrocodone was successful in reducing rate of high-risk prescription opioid use by cancer
survivors. Therefore, this study proposes to address these gaps in a population of older, ≥66 years of age,
cancer survivors by utilizing linked SEER-Medicare administrative claims for older cancer survivors diagnosed
with lung, colorectal, breast, and prostate cancer through the completion of three specific aims, as follows: 1)
Investigate the pattern of high-risk opioid use by years since diagnosis and examine differences by
age, sex, race, cohort for year of diagnosis, cancer diagnosis, and by region AND assess if
Hydrocodone Rescheduling was associated with a reduction of rate of high-dose opioid therapy for
older, long-term cancer survivors; 2) Examine the patient, provider, and hospital factors associated
with high-risk opioid use; 3) Assess if long-term cancer survivors, compared to non-cancer controls,
have a higher risk of experiencing high-risk opioid use and an opioid related ED visit or hospitalization.
We will utilize prevalence rates and interrupted time series, generalized estimating equations, and Cox
proportional hazard models and Fine and Gray regression models (for assessing competing risk of death) to
analyze aims 1, 2, 3, respectively. The long-term goal of this project is to inform providers, professional
organizations, and policy makers about high-risk opioid use rates in cancer survivors, the potential harms of
opioids, and previous successes policy attempts to reduce opioid prescribing in cancer survivors. Derrick will
receive further training in statistics, epidemiology, patient centered outcomes research, and writing which will
be crucial to finishing the proposed project and his future as a clinician-scientist. During his clinical years,
Derrick will be involved in research that aims to study patient’s perspectives and patient reported outcomes.
Throughout the three years of funding, Derrick will disseminate the results of his research in the form of
manuscripts and presentations at health services and pharmacoepidemiology conferences.

Public health relevance
PROJECT NARRIATIVE The population of long-term cancer survivors aged 65 years and older without receiving cancer treatment, is growing drastically, with many survivors being prescribed prescription opioids for chronic pain management. The proposed study will build upon the current scientific literature to examine trends in high-risk opioid use from 2008 to 2016, assess the impact of federal rescheduling of hydrocodone on opioid prescribing, and investigate the risk of experiencing an opioid related emergency department visit or hospitalization for older long-term cancer survivors. The results of this study will inform future clinical guideline and policy development concerning pain management and potential harms of opioid prescribing in older cancer survivors.